Minimally Invasive Targeted Injection of Thermoresponsive Hydrogels for Cardiomyopathy

Project Summary: The proposed research will develop an optimized strategy to interrupt the progressive
ventricular wall remodeling that characterizes ischemic cardiomyopathy (ICM). Cardiac failure following
myocardial infarction imposes a significant burden on the economy and society, and despite various efforts and
strategies, there is still no definitive treatment preventing progression of ICM. The pathology is characterized by
progressive thinning of the infarcted ventricular wall and dilation of the ventricular cavity coupled with elevated
ventricular wall stress, resulting in decreasing global cardiac function toward end-stage heart failure. To break
this pernicious cycle, we have advanced and refined an approach that reduces ventricular wall stress by injecting
designed hydrogels into the infarcted wall, leading to preserved cardiac geometry and function.
In this proposal we will leverage our extensive experience with cardiac injection therapy to integrate technological
advances into a clinically translatable system for ICM treatment. This will include (aim #1) evaluating the
functional, geometric, and histopathologic effects in a porcine ICM model by injecting one of three different types
of hydrogel based on a synthetic thermoresponsive hydrogel (poly(NIPAAm-co-VP-co-MAPLA)). Hydrogel 1 is
the non-porous form of this hydrogel. Hydrogel 2 develops porosity in situ by the integration of dissolvable
mannitol particles, and hydrogel 3 builds upon this porous hydrogel with the addition of extracellular matrix
components from enzymatically digested, decellularized cardiac tissue. In aim #2 a surgical robotic system will
be developed for safe, spatially controlled, and minimally invasive delivery of the hydrogels from aim #1 to the
ventricular wall. Innovations will include a navigation system based on preoperative 3D MRI images,
intraprocedure detection of coronary vasculature with ultrasound, epicardial mapping of impedence and
activation, clearing of pericardial adhesions, detection of heart wall thickness and controlled injection depth. In
aim #3, by segmenting MRI images collected prior to injection, animal-specific finite element models will be built
for mechanical modeling of cardiac wall stresses and strains. An optimization algorithm will be developed to
create prescribed injection patterns to maximally reduce von Mises wall stress based on the infarct architecture
and constraints on injection number and volume. The patient-specific developed approach will then be applied
to a new set of infarcted pigs to create a specific hydrogel (from aim #1 results) injection pattern that will be
accomplished by the robotic system developed in aim #2 and compared to the non-optimized injection pattern.
Collectively, through these investigations, we will advance a new, minimally invasive strategy to treat ICM in a
period where there are few options to interrupt the negative remodeling that leads to end-stage cardiac failure,
and by doing so, reduce the profound morbidity and mortality of this condition.

Public health relevance
PROJECT NARRATIVE A heart attack will strike an estimated 805,000 Americans annually, and many of those who survive will face deteriorating function of their heart muscle, leading to a reduced quality of life and death. This research seeks to advance an approach where a gel-like material is injected into the heart wall after a heart attack to prevent the deterioration in function. The injection process is being optimized so that injections would be made in the best locations for that person’s heart, using a small robotic system that is introduced onto the beating heart in a minimally-invasive manner.